Interdisciplinary Training Program in Immunology

PROJECT SUMMARY: This training grant, currently in its 40th year of funding, represents the primary support
for graduate students in the Immunology Training Program at the University of Chicago. The program functions
in a diverse environment where the basic biological sciences and the medical school are integrated within the
same division in a single campus in Hyde Park, Chicago, IL. It is embodied by the Committee on Immunology,
an interdisciplinary and interdepartmental academic unit that serves as the scientific community for
immunology graduate students, postdocs, and faculty at the University. The faculty of our Training Program is
composed of 34 distinguished trainers selected for their outstanding research and training records, their well-
funded laboratories and their dynamic involvement in all aspects of the program. They form a diverse, age- and
gender-balanced group whose research spans a broad spectrum of modern areas of immunology including
cellular and molecular immunology, biochemistry, genomics, systems biology, microbiome studies, molecular
engineering, and human immunology, with a proven record of interdisciplinary collaborations. New strength is
drawn from the recent recruitment of five internationally recognized senior faculty with expertise in
immunoengineering and immunogenetics, as well as three junior faculty with expertise in systems immunology,
mucosal immunology, and myeloid disorders. Predoctoral students receive advanced training through courses
focused on the critical analysis of primary literature and experimental design, with special emphasis on
computational skills, rigor and reproducibility, and the responsible conduct of research. The comprehensive
training includes a weekly Seminar Series, Work-in-Progress forum, and Journal Club, as well as an annual
Joint Immunology Retreat held with other top immunology programs in the Midwest. Career development is
enhanced through MyChoice, an institutional program enabling trainees to further develop academic skills and
gain exposure to a broad array of research-intensive career paths, as well as a partnership with the UChicago
Polsky Center for Entrepreneurship and Innovation. The Biological Sciences Division provides strong
institutional support, as shown by sustained financial and administrative support, the operation of cutting-edge
core facilities such as gnotobiotics, and the implementation of major initiatives such as the Duchossois Family
Institute, a new research institute aimed at harnessing the power of the microbiome and immunity for human
health. The Program is continuously and rigorously evaluated with respect to organization, leadership,
objectives and outcomes. This is one of the most outstanding and competitive training programs in the country,
as shown by the high retention and completion rates of our trainees (which include many students from
underrepresented minority backgrounds), their impressive publication rate (average of six publications per
trainee, including many first-author publications in journals such as Nature, Immunity, Cell Host & Microbe,
JEM, and PNAS), and their success in securing independent scientific careers.

Public health relevance
PROJECT NARRATIVE: This program trains the next generation of immunologists who will lead the innovative research, teaching, and biomedical entrepreneurship that is needed to advance basic science and develop new translational approaches for the prevention and treatment of autoimmune diseases and cancer, the improvement of organ transplantation, and the design of new and more effective vaccines. The funding will contribute to public health by supporting the training of highly skilled individuals who will join the national biomedical research workforce.